WAVE Regulatory Complex in Primary Immunodeficiency Disease and autoimmunity

PROJECT SUMMARY
Of the greater than 350 Primary Immunodeficiency Diseases (PID) in humans that have been identified to date,
the molecular basis of a significant number (~100) of PIDs have yet to be defined. Recently, 9 children (4 now
deceased) from 4 independent families were identified with severe PIDs that were linked to mutations in the
NCKAP1L gene encoding for Hematopoietic protein-1 (Hem-1), a conserved hematopoietic cell-specific
component the WAVE actin regulatory complex (WRC). Affected children presented with severe recurring
respiratory and skin infections, failed antibody responses to pneumococcal immunization (characteristic of B
cell immunodeficiency), dysregulated cytokine production, and autoimmunity. Although the cellular and
molecular functions of Hem-1 orthologues in flies and worms are relatively well characterized, there is a critical
knowledge gap regarding the cell specific functions of Hem-1 in the development and functions of primary
immune cells. Our longterm goal is to overcome this knowledge gap by dissecting the cell-specific roles of
Hem-1 in the development and functions of adaptive and innate immune cells. The objective of this proposal is
to disrupt Hem-1 expression in primary murine and human B lymphocytes in a B cell-specific manner to define
the roles of Hem-1 in B cell development, protective humoral immunity, and autoimmunity. Our Specific Aims
are to utilize inducible B cell specific gene targeting in mice, and CRISPR/Cas9 mediated Hem1 deletion in
“humanized mice”, to test our central hypotheses that B cell specific disruption in Hem1 results in: (1) impaired
B cell development in part due to reduced homing and retention of developing B cell progenitors in essential
lymphoid niches;(2) absent T cell independent antibody responses resulting in crippled protective immunity to
influenza A virus and Streptococcus pneumoniae, important community acquired respiratory pathogens; and
(3) hyper-responsive B cell signaling and T-bet driven transcriptome, resulting in increased autoantibody
production. To demonstrate feasibility, we have generated innovative mouse models to emulate Hem1 PID
patients including mice with a non-coding point mutation in Hem1 (Hem1pt/pt), Hem1 null (Hem1-/-) mice,
Hem1floxed (Hem1fl/fl) mice, as well as Hem1 deficient ”humanized mice” which contain Hem1 deficient
primary human hematopoietic cells. Based on our preliminary results which strongly support our hypotheses,
we expect that the results of these studies will be highly significant and will have a high impact because they
will define for the first time, the cellular and molecular mechanisms of how loss-of-function variants in
NCLAP1L disrupt B cell development, signaling, and protective antibody-mediated immunity resulting in PID
and autoimmunity. Because of extensive genetic heterogeneity of the 4 human PID families, limited number of
patients, and concurrent infections, the development of these innovative mouse model systems are critical for
dissecting the cellular and molecular mechanisms of how mutations in Hem-1 result in PID and autoimmunity,
and to provide much needed platforms to develop and test therapies to treat and cure Hem1 deficient children.

Public health relevance
Project Narrative The proposed research is highly relevant to the NIH mission and public health because it will help define why Children with Primary Immunodeficiency Disease due to mutations in the NCKAP1L gene encoding Hem-1 fail to respond to immunizations and exhibit high mortality associated with bacterial and viral infections.